In Vivo Prevention of Murine GVHD

8:4:A9B;9:/72/999-+03/C.-1/1-039791091.93 0-0>-1-.1-03-/3-0/-++093D3/9+.0/1>D
0&8#"L)9M:N;O&)#0P":#8$6'Q8M)RSN;):S$2':#7T2U"7M-?'NS"Q-/-013.9-309995390K9./09?+ 0.92-/96+ /0 9
I
I I
I I
I
I I
I I
089:2;9920<09+8=,-7299.9/9->0033/-/0..-/.-/013207993-/0-3//7.4/-3/5063-3?/5-8419@7 185 .98
2?-+4.4/41-35-.+--00+/0-0/0093-//D?1D+309/3//19-0/--3309/D1?9-++1.-.9101/3-9702493;?13/9+0D./9911/-199//-.D3-9/93+.-09.1.1931107/0911-3031-EF9G?-H03I9-/0-+0+3301909/9>3/-003093>D
,2;00Z/[<-/D9[K799S-20N0./S-7."/890Q77-/9'0-W\?00&V9#+1"56L)0M+.N@O9&915-273)53#-/P98V"#0;9$-.0'9Q;M09)3/33R0-S.N0)9?U1/",8M-93'9/N<S3-".9/Q037-;9.03/-D/D7-1<?-20;-000/9D7321//9909/097W-0 : 3/8-Y9-003/1X;2C//9D977W 4V6
,2/<9920/-787/-0VW@154=+9676X2W1900]99//9-0203/-//9?; 0.9829/9399/7.
;-/D7 9C=X ;0/D7 <2 Y-03/1;97 V V @
0K9./09?+ 0.92-/9;0933-01,-3/-./37 = ;0/D70 9 2//97 =
0-0.97
012456789 4 9 64 5
!"#$ &'()*
"0C!444445"19#724481494$04!10%2;1310218443!591B457#82719"181"942!11281;0019188938898444190C8929;;;;""838<3?;4#24&;522'1C5@1(@@2;*@4+AA,;-8=.,"/849101-."2+,4$45891<109<299('8201'9,9(4:(34==$#9(131193924882599981291111428188824888394::9<2244494662814995888941819<29919892261214495414820<<421522889BB926488190699421215>9884334494222711838492271
;18748 F98<2199889 #491 838684<2188 21
#"4D5C!9 E"<;"D<#"D =D# #1348482 292012>9
D2911295:98:G2C849444441 ===888999111888:::222666"<08;<481241384414<44892C8 ###444999111 888333888666888444<<<222111888888 222111
HIJKLNJOPQRLSTUVWJXWYYZ [R \WZ
]4X^6W4V_YYWl`9SLP3R8W6`814RZ8W9a`48P4Rb32W2T8V9SL1c99R695Yc19WjZ9_9IJ41K9L438W8J85O1:P9QR8L1S1T9ZV9W4J45T4WY9Y&Z5d'9Y(SZ*V+O4,W4-Y.R,2e/09V-_.6+1W2,5PW1f04S2Z9(VP'K9V0S3'R8L,1(L:(I73J8(O38Wk9PR^9V_WZ`WTS^STTWYYYSLWgZh^PRJ V_W^RYYReSLfYSZVi
□
0C mno9@mp@p@;129D41234@ppop@pm # "2@npqB@@@A
0439m rRPJsKfWtuTRLVSLIWa
" 54989414984v+8w2w+x.7,224239926698y989:44412z3442z8

Public health relevance
Our expert team will develop novel approaches and gain biological insights into immune system control by IL33, innate lymphoid type 2 cells {ILC2s) and regulatory T cells (Tregs). Our findings have broad implications for the use of immune regulatory cell therapies in controlling adverse immune responses by focusing on translational applications for hematopoietic stem cell and solid organ transplantation and autoimmunity settings.